Center for Childhood Obesity Prevention - Biostatistics Core

PROJECT SUMMARY
The mission of the Biostatistics Core is to provide comprehensive statistical support and targeted statistical
training to investigators in the Center for Childhood Obesity Prevention (CCOP). This dedicated Biostatistics
Core plays a vital role in supporting the CCOP by providing high quality expertise from biostatisticians focused
on the Center’s research and training missions related to prevention of childhood obesity. In Phase 2, the
Biostatistics Core will continue to support Center investigators on their research projects and in their
development as independent investigators through the following aims:
1. Develop statistical collaborations with all Center research project and pilot project leaders, spanning the
entire timeline from study inception to completion.
2. Provide statistical mentoring, education, and training.
3. Aid investigators in identifying, accessing and using relevant external and institutional data resources for
addressing the problem of childhood obesity.
This centralized resource for statistical collaboration, matched to the needs of Center projects, will improve the
efficiency and methodological rigor of COBRE research projects and activities. The targeted mentoring,
educational, and training activities will increase the statistical and research acumen of Center investigators,
enhancing their preparation for independent research careers. Together with the Center’s other research
cores, the Biostatistics Core contributes to the development of a solid infrastructure for an ongoing team-based
research program in childhood obesity.